Conference on Control of Renal Function in Health and Disease

PROJECT SUMMARY/ABSTRACT The purpose of this proposal is to seek support for a travel award program for the American Physiological Society (APS) conference entitled Control of Renal Function in Health and Disease scheduled for June 23rd-29th, 2019 in Charlottesville, VA. Interest in the control of renal function and renal hemodynamics has grown considerably over the past couple decades as the incidences of hypertension and kidney injury in the U.S. have ballooned. Thus, there is great need in the scientific community for meetings focused on the mechanisms underlying the control of renal hemodynamics and hypertensive kidney injury. The overall goal of the 2019 Control of Renal Function in Health and Disease conference is to bring together basic scientists and clinician scientists to discuss new ideas about renal and cardiovascular function and the mechanisms underlying kidney injury. As such, the conference objectives are to: 1) gather a critical mass of expert basic and clinical researchers with interests in the mechanisms underlying renal and cardiovascular disease and renal hemodynamics to promote the exchange of ideas, develop scientific relationships, and to promote potential future collaborations; 2) present largely unpublished data so that the current state of the art is communicated; and, 3) promote the interest of early career investigators and trainees in developing new studies into the roles of novel signaling mechanisms, inflammation, hypertension, sex disparities, circadian influences and related issues that contribute to renal and renal vascular dysfunction. In order to achieve the conference objectives above, the organizing committee has developed a meeting program that focuses on novel areas of renal function and disease including symposia on the following topics: obesity, diabetes, and metabolic syndrome; sex steroids and the kidney; developmental programming of kidney disease; genetics, epigenetics and the kidney; and immunology and the kidney and circadian biology of kidney function. Symposia will also cover recent advances in the traditional areas of renal hemodynamics, acute kidney injury, chronic kidney disease and podocytes, autacoids and the kidney, and hypertension and the kidney. In order to promote the interest of trainees and early career investigators in the field and their participation in the conference, we propose to administer an NIH-funded travel award program for trainees and early career investigators.

Public health relevance
PROJECT NARRATIVE The purpose of this proposal is to seek support for a travel award program for the American Physiological Society (APS) conference entitled Control of Renal Function in Health and Disease scheduled for June 23rd-29th, 2019 in Charlottesville, VA. This conference provides a forum for researchers studying the control of renal function to present their newest research findings on topics related to the effect of obesity, diabetes, and metabolic syndrome on the kidney; sex steroids and the kidney; developmental programming of kidney disease; genetics, epigenetics and the kidney; immunology and the kidney; circadian biology of kidney function; renal hemodynamics, acute kidney injury, chronic kidney disease and podocytes, autacoids and the kidney, and hypertension and the kidney. The meeting will ultimately put us on the path to finding better clinical treatments that prevent renal injury and chronic kidney disease, the latter affecting approximately 30 million adults in U.S.